Participant Engagement Unit

The PEU will be responsible for direct participant engagement to enroll patients into the Washington University (WU)-PE-CGS program. Under the direction of PIs Fields and Drake, we will leverage investigator and institution-level expertise to establish a network for direct patient engagement. We will prioritize 8 areas that are directly tied to the PEU Specific Aims: (1) find; (2) contact; and (3) consent participants; (4) obtain tumor/normal samples and clinical/meta data; (5) create and prospectively maintain patient, specimen, and ongoing treatment data; (6) report
research findings directly to study participants using cutting-edge, innovative, informatics-driven methodologies that leverage unique partnerships; (7) guide patients through the “flow” of the WUPE-CGS program, providing oversight of program-wide integration; and (8) bi-directionally interact
with the other WU-PE-CGS “Units” for ongoing, iterative refinement of program-wide protocols
based on prospective study of participants.
To achieve success in these seven areas, we need novel paradigms for engagement. The WUPE-CGS has developed several innovative approaches following our overall mission to “develop,
implement, evaluate, and modify.” First, we have partnered with three world-class patient interest
groups that have significant experience in working directly with patient-partners in advancing
cancer care: The Cholangiocarcinoma Foundation (CCF), Fight Colorectal Cancer (FCRC), and
The Multiple Myeloma Research Foundation (MMRF). Second, we will leverage our institutionlevel strengths to directly address this RFA’s stated knowledge gaps of genomically
characterizing and engaging patients with tumor types (cholangiocarcinoma [CHOL]) and cancers
that require more research in specific populations (colorectal cancer diagnosed under the age of
65 [CRC<65] and multiple myeloma [MM]). By studying groups that have worse incidence and
prognosis we will develop insights to improve cancer outcomes for all populations. Third, we will
employ bi-directional, real-time, informatics-driven methods to interact with the EOU to evaluate
and iteratively refine our program to ensure that the WU-PE-CGS optimally finds, enrolls,
evaluates, and interacts with the participants.
The innovative and impactful aims of the PEU will address direct engagement of populations that
require more research within an environment of respect and access to the academic research
enterprise. Our partnerships with patient interest groups and patient-partners, leveraging of
investigator and institution-level expertise, adherence to PCORI rubrics, and ongoing
methodological refinement will result in impactful research across a broad group of cancer types